Impact of the COVID-19 pandemic, SARS-CoV-2 infection and social determinants of health on pregnancy complications, birth outcomes and post-pregnancy maternal cardiovascular and mortality outcomes Div

PROJECT SUMMARY OF PARENT GRANT:
Nationally, South Carolina (SC) ranks among the worst for poor pregnancy outcomes and high maternal and
infant mortality rates, with vast racial/ethnic disparities present. Infection with the novel SARS-CoV-2 during
pregnancy has been associated with pregnancy complications and poor infant and maternal outcomes including
mortality. Moreover, the effect of social determinants and inequities in healthcare received and health outcomes
have been heightened by the COVID-19 pandemic caused by SARS-CoV-2. Cardiovascular risk factors during
pregnancy (e.g., obesity, diabetes, and hypertension) and pregnancy complications such as pre-eclampsia are
common, can result in morbidity and mortality for the mother and the baby, and are well-known risk factors for
maternal cardiovascular and vascular disease short and long-term. Infection with SARS-CoV-2 during pregnancy
has also been related to complications (e.g., intensive care unit (ICU) admission, invasive ventilation, myocardial
infarction, embolism). Less information is available regarding the impact of the COVID-19 pandemic or
specifically SARS-CoV-2 infection on maternal and infant morbidity and mortality. The objective of our study is
to understand the impact of both the COVID-19 pandemic and infection with SARS-CoV-2 on the risk of maternal
and infant morbidity and mortality including pregnancy complications (e.g., pre-eclampsia, ICU admissions,
mechanical ventilation), adverse birth outcomes (e.g., preterm birth, small for gestational age), and maternal
cardiovascular events (e.g., coronary heart disease, stroke, embolism) during and post-pregnancy. Data from
statewide administrative datasets (e.g., hospitalizations, vital records, Medicaid, positive COVID-19 tests) will be
linked to create a diverse, longitudinal cohort of women who gave birth between 2018-2021 with at least one
year of follow-up through 2022. Approximately 45,000 live birth pregnancies take place in SC each year for a
total of ~180,000 deliveries anticipated over the 4-year study period. As of June 1, 2021, 2600 pregnant women
in SC were diagnosed with COVID-19. The proposed project aims to evaluate the impact of the COVID-19
pandemic (Aim 1) and the impact of SARS-CoV-2 infection (Aim 2) at the population level in SC on (1) pregnancy
complications, adverse birth outcomes, maternal cardiovascular events, and maternal and infant mortality; (2)
maternal one-year post pregnancy cardiovascular and mortality outcomes; and (3) to examine differences by
race/ethnicity, social vulnerability, distance to main medical facility, and pre-pregnancy obesity and diabetes.
This study will be among the first to evaluate the COVID-19 pandemic and SARS-CoV-2 infection during
pregnancy in relation to maternal and infant morbidity and mortality in a population-based study. Determining
the impact of the COVID-19 pandemic and SARS-CoV-2 infection on infant and maternal morbidity and mortality
and the extent of social and racial-ethnic differences is critical to improving pregnancy outcomes and health
disparities in the U.S. Findings are expected to inform clinical care of pregnant women and public health policy.

Public health relevance
PROJECT NARRATIVE The global COVID-19 pandemic caused by SARS-CoV-2 has highlighted the extent to which social determinants and inequities impact healthcare received and health outcomes. This project will evaluate maternal and infant effects following the COVID-19 pandemic and SARS-CoV-2 infection during pregnancy including pregnancy complications, adverse birth outcomes, maternal and infant mortality, and maternal one-year post pregnancy cardiovascular and mortality outcomes with a focus on social determinants of health and racial/ethnic differences. Better understanding of the impact of the COVID-19 pandemic and SARS-CoV-2 infection during pregnancy on maternal and infant morbidity and mortality is needed to guide clinical practice and public health prevention efforts for at-risk populations.